Whole genome sequences in ethnically diverse individuals to comprehensively characterize the genetic mechanisms of dyslipidemias

PROJECT SUMMARY / ABSTRACT
Coronary heart disease is the leading cause of death worldwide. Characterizing the inherited basis of plasma
lipids, the strongest risk factor for coronary heart disease, has led to key biological and clinical insights. Large-
scale deep-coverage whole genome sequencing is now feasible and offers the opportunity to characterize full
genomic variation within a given individual. For any one individual, however, the interpretation of genomic
variation is limited by 1) ethnic-specific impacts, 2) prediction of functional impact, particularly for rare, non-
coding variants, and 3) comprehensive interpretation frameworks. The goal of this R01 proposal is to fully
characterize the inherited basis of plasma lipids through a novel ‘trans-omics’ approach – complementing
whole genome sequencing with novel methods, genomic features, and clinical frameworks. In Aim 1, we will
discover novel genomic variation from ~600,000 ethnically-diverse individuals and associate with plasma lipids.
We will complementarily use annotation- and data-driven bioinformatic approaches to identify novel genetic
regions. In Aim 2, we will examine the role of larger genomic features, called structural variants, in the role of
lipids in these individuals. We will develop new methods to characterize their functions and incorporate them
into association frameworks for both common and rare structural variants. We will jointly model the monogenic
and polygenic components for risk of familial hypercholesterolemia. In Aim 3, we derive a comprehensive
whole genome sequence diagnostic test for plasma lipids with a harmonized quantitative framework spanning
variant types and their prevalences. In addition to showing their diagnostic yield for lipid disorders beyond rare
commonly tested coding variants, we will also demonstrate their clinical utility for coronary heart disease risk
prediction beyond standard lipids. Using longitudinal lipids datasets, we will characterize how this whole
genome risk model explains lipid burden and variation phenotypes, including while lipid-lowering medicines are
prescribed or titrated. This work leverages data being generated within the NHLBI Trans-Omics for Precision
Medicine (TOPMed) program, NIH All of Us Research Program, UK Biobank, and others. We have extensive
expertise in whole genome sequence analysis, statistical genetics, computational genomics, and
cardiovascular medicine. This proposal includes methodological and computational innovations, and builds on
established collaborative relationships between investigators with complementary strengths. Completion of our
aims will yield novel insights to inform prevention, diagnosis, and treatments for coronary heart disease.
Furthermore, we will demonstrate a broad framework for trans-omics analysis to identify causally relevant
genomic variants for both research and clinical genetic applications.

Public health relevance
PROJECT NARRATIVE Characterizing the genetic basis of plasma lipids has spurred many key paradigms for preventing coronary heart disease – biological insights, risk prediction, and medicines. Whole genome sequencing now offers the prospect of identifying all the potential genetic factors influencing lipids. The goal of this proposal is to surmount several methodological, analytical, and computational challenges to improve risk prediction and tailor preventive care as well as find new genes, which can be therapeutically targeted to efficiently reduce the risk for coronary heart disease.